A Motivation-Based Adolescent Vaping Typology to Inform Cessation Interventions

PROJECT SUMMARY/ABSTRACT
Since the introduction of e-cigarettes in the U.S. in 2007, there has been a dramatic increase in the prevalence
of e-cigarette use among adolescents. These high prevalence rates have been driven, in part, by beliefs that e-
cigarettes are less harmful than combustible cigarettes. Unfortunately, mounting evidence indicates that e-
cigarettes pose significant health risks. E-cigarettes also contain nicotine, which can interfere with normal brain
development. Because it is still developing, the adolescent brain is more vulnerable to the negative effects of
nicotine exposure, putting adolescent e-cigarette users at greater risk of nicotine dependence as well as
reduced impulse control and deficits in attention and cognition. Thus, although many had hoped that e-
cigarettes would serve as a smoking cessation tool, they may, in fact, be ushering in a new generation of
individuals dependent on nicotine. Therefore, we face an urgent need to promote e-cigarette cessation among
adolescents. Unfortunately, the empirical literature on e-cigarettes has not been able to keep pace with their
rapid increase in popularity. These knowledge gaps combined with the unique challenges of working with
adolescent e-cigarette users have hindered the development of empirically supported e-cigarette cessation
interventions for this population, and we currently lack targeted e-cigarette cessation interventions that are
developmentally appropriate, grounded in empirically supported theories of behavior change, and acceptable
to adolescents. To create such interventions, formative research is needed to better understand the different
types of adolescent e-cigarette users based on their motivations for use rather than patterns of use.
Identification of such a typology is critical as each type will have distinct cues, use patterns, beliefs, and
preferences resulting in the need for type-specific interventions. Moreover, greater adolescent engagement is
needed to ensure that the content of these interventions as well as the messaging surrounding them are
acceptable to adolescents and take into account their perceptions of their own use. A mixed methods approach
will be utilized to gather formative data on types of adolescent e-cigarette users and interventional targets
specific to each type to inform the development of tailored cognitive behavioral e-cigarette cessation
interventions for each type. A sample of 1200 high school students who have used an e-cigarette in the past
month will be recruited. Self-report data will be used to identify e-cigarette user types based on motivations for
use as well as cognitive and behavioral correlates of each type. Focus groups with users of each type as well
as students who have successfully quit using e-cigarettes will provide further information about cognitive and
behavioral intervention targets and cessation needs and preferences. The findings of this project will fill critical
knowledge gaps that will result in the development of cognitive behavioral e-cigarette cessation treatment
protocols specifically designed for adolescent e-cigarette users and tailored to their specific use type that will
be evaluated in future clinical trials.

Public health relevance
PROJECT NARRATIVE Due to the dramatic rise in adolescent e-cigarette use, we face an urgent need to promote e-cigarette cessation among adolescents; unfortunately, although most adolescent e-cigarette users are interested in quitting and have made at least one quit attempt, no empirically validated e-cigarette cessation interventions are available. For such interventions, formative research is needed to develop (1) a motivation-based typology of adolescent e-cigarette users in order to identify the cognitive and behavioral intervention targets specific to each type of user and (2) an understanding of adolescent views to further inform intervention content (e.g., examples of type-specific cues and maladaptive cognitions) and ensure maximal acceptability, engagement, and efficacy of the resulting interventions. The data from this project will inform the creation of subsequent adolescent e-cigarette cessation interventions that are targeted to specific use motivations, developmentally appropriate, grounded in cognitive behavioral principles, and highly engaging and acceptable to users.